The path to the parous brain: allopregnanolone-mediated mechanisms at GABAA receptors.

Project Summary
By age 49, nearly 85% of women in the US will have given birth at least once. The pregnancy and postpartum
periods are marked by extreme hormonal fluctuations that can induce long-lasting changes in the brain, but
mechanistic insight into how the unique hormonal milieu that characterizes pregnancy produces stable
alterations in neural activity and behavior is lacking. The medial prefrontal cortex (mPFC)—a brain region critical
to higher-order processes like executive function, emotion regulation, and decision-making—has been especially
under-studied in parous animals, despite reports of alterations in these functions in parous women. Our lab has
collected intriguing preliminary data in rats suggesting that during late pregnancy, neural activity in the mPFC is
markedly suppressed compared to that of nulliparous (NP) animals. After weaning, however, we found that
mPFC activity swings well past that of NP, suggesting that the brain undergoes an over-compensatory rebound
from the pregnancy after parturition. The main goal of this proposal is to investigate the specific role that the
hormone allopregnanolone (AP)—whose levels are notably high during late pregnancy—plays in producing this
effect. AP acts as a positive allosteric modulator at the GABAA receptor, making it a potential driver of the neural
inhibition we observe in late pregnancy. Here we will test the hypothesis that allopregnanolone-mediated
GABA signaling is both necessary and sufficient for producing the long-term alterations in mPFC
function observed in primiparous animals. The Aims that comprise this proposal integrate pharmacological,
chemogenetic, and CRISPR/Cas9-based manipulations to either block or mimic AP-related processes during
late pregnancy. We will then use fiber photometry to measure mPFC activity during recall of conditioned fear
(which relies on optimal mPFC function) at post-weaning timepoints. Together, these experiments are able to
establish a causal, mechanistic link between the pregnant and primiparous brain.

Public health relevance
Project Narrative Pregnancy is characterized by marked changes in circulating hormones that can induce long-lasting changes in the brain. The goal of this project is to determine how the hormone allopregnanolone may induce a robust neural inhibition in the medial prefrontal cortex during pregnancy, resulting in over-compensatory actions that persist well after birth. Our work will provide much-needed insight into the development of the brain post-pregnancy.